Neural circuits for stress-impaired extinction learning

Project Summary
Clinical disorders of fear and anxiety, including trauma- and stressor-related disorders, represent an enormous
public health burden. Cognitive-behavioral therapies, such as prolonged exposure therapy, have proven to be
remarkably effective in reducing pathological fear in patients with these disorders. Nonetheless, there are a
number of factors that limit the efficacy of exposure therapy. In particular, stress undermines exposure-based
therapies by impairing extinction learning and promoting fear relapse. Despite years of work elucidating the
neural circuitry for extinction, the neural mechanisms responsible for stress-induced extinction impairments
remain poorly understood. One possibility is that stress dysregulates neuronal activity in the medial prefrontal
cortex (mPFC), a brain area that is critical for extinction learning. In support of this possibility, we have
recently shown that footshock stress causes lasting decreases in the spontaneous firing of neurons in the
infralimbic (IL) division of the mPFC in rats. Decreases in IL firing were associated with an “immediate
extinction deficit” (IED), an extinction impairment that occurs when extinction is performed soon after fear
conditioning (a stressor). Importantly, systemic administration of propranolol, a ß-noradrenergic receptor
antagonist, prevented both the stress-induced depression of IL firing and the IED, suggesting a role for locus
coeruleus norepinephrine (LC-NE) in this phenomenon. Although these data reveal that noradrenergic
transmission is involved in the stress-induced depression of mPFC firing, the neural circuit by which stress
perturbs mPFC firing is unknown. Interestingly, we have found that propranolol rescues the IED when
delivered to the basolateral amygdala (BLA), but not the IL. Based on this work, we propose a novel hypothesis
that stress-induced NE release from the LC recruits an inhibitory BLA->IL circuit that dampens activity in IL
principal neurons to impair the acquisition and retention of long-term extinction memories. We propose three
specific aims to test this hypothesis using a combination of in vivo electrophysiology, functional circuit tracing,
and pharmacogenetic manipulations (e.g., `designer receptors exclusively activated by designer drugs' or
DREADDs). The first specific aim of the project examines whether LC-NE projections to the IL or BLA are
necessary and sufficient for stress-induced changes in mPFC firing and extinction learning deficits. The second
specific aim examines explores whether BLA neurons projecting to the IL or PL mediate these effects. The
third specific aim determines whether parvalbumin interneurons (PV-INs) in the mPFC are recruited by LC-
NE activation and mediate the immediate extinction deficit through feed forward inhibition by BLA afferents.
The outcomes of these aims will advance a novel circuit mechanism for stress-induced extinction impairments.
Understanding this mechanism will facilitate the development of novel pharmacotherapeutic approaches that
optimally engage mPFC circuits to facilitate extinction learning under stress.

Public health relevance
Project Narrative Stress undermines behavioral interventions after trauma by impairing extinction learning and promoting fear relapse. Despite years of work elucidating the neural circuitry for extinction, the neural mechanisms responsible for stress-induced extinction impairments remain poorly understood. In this project, we seek to uncover the brain circuits involved in stress-impaired extinction learning.